Brain structure and function and the CNS HIV reservoir in older people living with HIV

PROJECT SUMMARY / ABSTRACT
People living with HIV (PWH) often exhibit a spectrum of cognitive, motor and mood symptoms, together referred
to as HIV-associated neurocognitive impairment (HIV-NCI). HIV-NCI is estimated to affect over 40% of PWH
and is more common as PWH age. HIV can enter the CNS within days of initial infection, and individuals with
suppressed plasma viral loads might still have detectable HIV in their cerebrospinal fluid (CSF) for up to a
decade, leading to inflammation within the CNS and subsequently HIV-NCI. Inflammation is believed to start
very early in the disease process and precede overt clinical signs and symptoms of NCI. Identifying biomarkers
of neuroinflammation related to presence of HIV virus in the CNS could help detect PWH who are now
experiencing the neuroinflammatory effects of HIV.
While incompletely understood, HIV-NCI is believed to be linked to chronic inflammatory processes in PWH,
since immune responses may lead to both repair and damage in the CNS. Chronic inflammation may also
contribute to changes in brain structure and altered connectivity. Our own prior work of 21 PWH ages≥50 shows
that heightened segregation in the brain correlates with inflammatory biomarkers in PWH, while higher CSF NfL
is related to higher markers of neuroinflammation or microglial activity. Our findings highlight the potential
relationship between inflammation, neurodegeneration and functional connectivity (FC).
Our overall goal in this proposal is to determine if the impacts of FC deficits, neuroinflammation,
neurodegeneration or greater white matter hyperintensity (WMH) volume in HIV-NCI are mediated by CNS HIV
viral persistence. We aim to (1) evaluate the specific contribution of HIV in the CNS to associations with
inflammation, brain structure and function and cognition, and (2) examine whether detectable HIV RNA in the
CSF mediates the associations between inflammation and neuronal injury, cerebrovascular disease and
Alzheimer’s pathology in older PWH.
Leveraging our team’s expertise in the fields of neuroHIV, biomedical imaging and virology, we leverage an
existing research infrastructure and banked biospecimens from an existing cohort of older PWH at UNC. We will
examine if the associations between fluid biomarkers of inflammation using next-generation proteomics and
multimodal MRI markers of aging differ in PWH age≥50 with detectable vs. undetectable HIV RNA in CSF. We
will also examine if the associations between biomarkers of inflammation and biomarkers of neuronal injury (NfL),
cerebrovascular pathology (WMH volume) and AD pathology (NfL, phosphorylated tau217) are differentially
impacted by presence of HIV within the CNS. The results of this study will provide an understanding of the
mechanistic pathways by which viral presence in the CNS affects brain function and connectivity and
neuroinflammation and provide potential future therapeutic targets to reduce the burden of HIV-NCI.

Public health relevance
PROJECT NARRATIVE Aging-associated comorbidities, such as neurocognitive impairment (NCI), among people living with HIV (PWH) can lead to high morbidity, mortality and healthcare costs. HIV may persist in the brain despite adequate viral suppression in blood with antiretroviral treatment. Our overall goal in this proposal is to disentangle the effects of HIV viral replication within the brain, inflammation, alterations in brain structure and function that impact NCI in PWH by determining if the impacts of brain functional connectivity deficits, neuroinflammation, neurodegeneration or greater white matter hyperintensity volume are mediated by CNS HIV viral persistence.